Investigating Membrane Alterations as a Mechanism of Acid Tolerance in Cariogenic Bacteria

Project Summary/Abstract
Dental caries is the most common chronic infectious disease globally and is caused by the formation of acid-
producing bacterial biofilms on the tooth surface, which demineralize and destroy the protective underlying
enamel barrier. Although the efficacy of fluoride treatments (the contemporary standard in caries prevention) is
well-documented, the current prevalence of the disease clearly illustrates that fluoride alone is insufficient to
prevent caries in many situations. Therefore, increased understanding of disease pathogenesis and exploration
of novel preventative strategies are objectives worthy of attention. Regardless of the microbial taxa involved,
bacterial acid-tolerance is an indispensable factor in caries pathogenesis. The known caries pathogen
Streptococcus mutans increases the proportion of unsaturated fatty acids (UFAs) in its plasma membrane in
response to environmental acidification—an adaptation required for acid-tolerance and virulence. Preliminary
data indicates that several other Gram-positive oral taxa, including the caries-associated species, Lactobacillus
casei, modify their membranes in a similar manner in response to environmental acidification. This proposal
addresses a number of currently unanswered questions raised by these observations. Aims 1 and 2 of the
proposed research will determine the scope of this response to acid stress across the oral microbiome, in single
taxa or in a community setting. Aim 3 of this proposal will elucidate how these UFAs are protective against acid-
mediated damage. These aims will be accomplished using bioinformatics tools, basic molecular microbiology,
an ecologically-relevant and complex in vitro oral biofilm model, and mass spectrometry/lipidomics. Successful
completion of the proposed research will answer pertinent questions regarding caries pathogenesis in a multi-
species setting and is likely to open the door to investigation of novel anti-caries therapeutics which, while
targeting acidophiles, function regardless of the presence and abundance of S. mutans. The candidate, Dr.
Jonathon Baker, has a longstanding interest in the microbiology of dental caries. Upon completion of the K99
(mentored) phase of this award, his goal is to become an independent PI at a leading research university, where
he plans to continue research on the modifications that bacteria make to their membranes to combat
environmental stresses, while leveraging acquired data to develop novel therapeutics. A funded K99/R00
proposal will allow Dr. Baker to develop skills necessary to both complete the proposed research (training in
mass spectrometry/lipidomics) and subsequently become an independent research scientist (training in didactic
lecturing, mentoring, and grantsmanship). Dr. Baker’s mentors, Drs. Victor Nizet and Pieter Dorrestein, and
environment (J. Craig Venter Institute and UC San Diego) have been carefully selected to provide high-quality,
diverse scientific and collegial support, as well as state-of-the-art facilities, to ensure successful completion of
this research program and the proposed career development goals.

Public health relevance
Project Narrative The known dental caries pathogen Streptococcus mutans is able to survive an acidic environment and cause disease by increasing the proportion of unsaturated fatty acids in its cell membrane. The proposed research will determine the extent of this acid stress response among oral bacteria, and the mechanism by which unsaturated fatty acids protect against environmental acid stress. Results generated from this study will improve understanding of the pathogenesis of dental caries, the world’s most common chronic infectious disease, and will likely open the door to investigation of novel anti-caries therapeutics.